Regenerating cranial suture

ABSTRACT
Craniosynostosis is a debilitating pediatric condition characterized by premature cranial suture fusion, resulting
in abnormal skull shape, blindness and neurologic deficits. The prevalence of craniosynostosis is at
approximately 1 in 2,500 live births, which is one of the highest incidences of congenital malformations of the
skeletal system. We have assembled a strong collaborative team combining Dr. Ma's expertise in 3D tissue-
engineering scaffolds and biomolecule delivery for craniofacial tissue regeneration, Dr. Mishina's expertise in
suture development and midline craniosynostosis model, and Dr. Hatch's expertise in the mechanisms
underlying coronal craniosynostosis. In the Specific Aim 1, we will develop 3D scaffold-based
microenvironment to maintain suture mesenchymal stem cells; in Aim 2, we will establish 3D culture system to
regenerate and maintain bone-suture-bone tissue composite; in Aim 3, we will establish the efficacy of
engineered scaffolds and controlled release systems for preventing craniosynostosis in vivo. By accomplishing
these specific aims, we will develop a novel strategy to cure or diminish the severity and recurrence of
craniosynostosis in humans, hence significantly improving patient quality of life.

Public health relevance
Craniosynostosis is a debilitating pediatric condition characterized by premature cranial suture fusion, resulting in abnormal skull shape, blindness and neurologic problems. In this project, a multi-disciplinary team composed of complementary bioengineering, biological and medical experts, will develop regenerative approach to treating children with this debilitating condition in the future.